Machine-guided design of chaperone-mimetic polymeric carriers for ribonucleoprotein delivery

PROJECT SUMMARY
In this Trailblazer R21, our interdisciplinary team [polymers, machine learning (ML), and hematopoietic
stem and progenitor cells (HSPCs)] will innovate ML-guided polymer discovery pipelines for intracellular delivery
of ribonucleoproteins (RNPs). Chaperone-mimetic polymers developed in this project will augment the safety
and site-specificity of genome editing by counteracting intracellular RNP misfolding and performing conforma-
tional quality control. Transfer learning frameworks innovated in this project will streamline the discovery of pol-
ymeric RNP carriers in hard-to-expand data-scarce cells such as HSPCs that are otherwise recalcitrant to ML-
guided experimentation. RNPs are expensive to express and purify. Sadly, electroporation consumes substantial
amounts of RNPs, exacerbating already high RNP costs. Polymers are not only affordable to manufacture but
also load RNPs efficiently, thereby lowering the costs of RNP therapeutics. However, heuristic optimization of
polymer lengths, architectures, or compositions is inefficient and experimentally onerous. We will pioneer ML
frameworks that address 2 conceptual blind spots in RNP delivery: conformational quality control of intracellular
RNPs (misfolded RNPs trigger deleterious edits) and tailoring polymers for data-scarce HSPCs.
Protein payloads such as RNPs unfold during endosomal translocation but they must recover conforma-
tional integrity in the cytosol. Otherwise, misfolded RNPs will fail to discriminate between target and off-target
DNA sequences, jeopardizing the safety of genome editing. In Aim 1, we will engineer chaperone-mimetic
polymers that refold RNPs back into catalytically competent conformations, augmenting the precision and effi-
ciency of genome editing. During RNP refolding, polymers must promote peptide self-sorting while preventing
aggregation. This requires careful modulation of polymer cationicity and hydrophobicity. Current tools fail to ex-
plore vast design spaces along information-efficient trajectories. In contrast, Bayesian optimization (BO) will
rapidly identify polymeric chaperones-cum-nanocarriers of optimized hydrophobicity and cationicity.
RNP delivery to HSPCs has transformed the therapeutic landscape for hemoglobinopathies but electro-
poration-based therapeutics such as exa-cel are prohibitively expensive ($2M per patient). Polymers load RNPs
efficiently, consuming fewer RNPs per dose than electroporation and dramatically improving affordability. How-
ever, polymers have met with limited success in delivering RNPs to HSPCs. Importantly, HSPCs are challenging
to expand into large cell populations, which makes them ill-suited for testing large polymer libraries via data-
intensive ML approaches. If we start with 1 million HSPCs, only 3 polymer–RNP complexes can be tested even
in miniaturized experimental set-ups; a 150-strong polymer library will require 50–100 million HSPCs, which is
experimentally onerous. Instead, in Aim 2, we will transfer information from data-rich cellular domains to tailor
polymers for data-scarce HSPCs via transfer learning. This TrailBlazer R21 will alleviate the financial burdens of
RNPs by developing an innovative ML-driven blueprint to unlock the potential of polymeric nanocarriers.

Public health relevance
PROJECT NARRATIVE In this Trailblazer R21, our interdisciplinary team will develop machine learning-guided design platforms to innovate polymeric nanocarriers of ribonucleoproteins (RNPs) that augment the safety, efficiency, and afford- ability of genome editing. In Aim 1, Bayesian optimization will guide the synthesis of chaperone-mimetic poly- meric carriers that counteract ribonucleoprotein misfolding during endosomal translocation and facilitate on-tar- get genome editing. In Aim 2, transfer learning will establish polymer design criteria for delivering ribonucleopro- teins to data-scarce yet clinical valuable cellular targets (hematopoietic stem and progenitor cells), where tradi- tional polymer optimization would otherwise prove unfruitful.